PIVOTAL EFFICACY STUDY OF INHIBITION OF GASTRIC ACID SECRETION BY PANTOPRAZOLE

The objective is to identify the regimens of intravenously (IV) administered pantoprazole that would decrease and maintain acid secretion at less than 10mEq/hr in patients with Zollinger-Ellison syndrome (ZES) with or without multiple endocrine neoplasia-type I (MEN- I) syndrome who have not undergone partial gastrectomy and at less than 5 mEq/hr in those patients with ZES with or without MEN-I who have undergone partial gastrectomy and to minor safety.